Targeting Endothelial Cell Mineralocorticoid Receptor Against Aortic Aneurysm in Females

Project Summary
Abdominal aortic aneurysm (AAA) is a severe vascular disease affecting millions of Americans with high
morality. Currently, no medication has been approved to treat this devastating disease. Women are less and
later to develop AAA than men. Nevertheless, AAA in women is more aggressive. It grows faster. It is more
likely to rupture at smaller diameters, resulting in higher mortality, with worse morbidity after surgical repair.
Smoking promotes AAA in both men and women, but women who smoke are at higher risk for AAA than men.
Estrogen (E2) has long been believed to protect premenopausal women from AAA. However, its effect on AAA
in animal models and human clinical trials is controversial. Several AAA animal models have been developed
and have contributed to our current understating of AAA. However, one of the common limitations of these
animal models is to use young animals to study AAA, which occurs mainly in older people. To fill this significant
gap, we developed a relatively new AAA mouse model that requires using older male mice, activation of
mineralocorticoid receptor (MR) by aldosterone (Aldo), and high salt intake to induce AAA. Surprisingly, we
found that Aldo and salt (Aldo-salt) only induced AAA in male mice but not in female mice unless female mice
were subjected to ovariectomy (Ovx) or nicotine. Mechanistically, MR was upregulated by Aldo-salt with Ovx or
nicotine in endothelial cells (EC) in the aorta with accumulation in the nucleus, indicating E2 may protect
female mice from AAA via suppressing MR expression and/or nuclear translocation in EC in the aorta.
Interestingly, Per2, a core circadian gene, interacts with ER and MR and is required for E2 to suppress MR
expression. Moreover, genetic deletion of MR in EC, but not smooth muscle cell and myeloid cells, inhibited
Aldo-salt-induced AAA, concordant with a reduction in ICAM1 upregulation in EC and neutrophil (N)
infiltration in the aorta. Based on the literature and robust evidence from our preliminary data, we hypothesize
that E2 inhibits Aldo-salt-induced MR protein upregulation and nuclear translocation via ER/Per2/MR
interaction in EC in the aorta, thus protecting female mice from ICAM1 upregulation, Nφ infiltration, and aortic
aneurysm. Aim 1 is to define the mechanism by which E2 protects Aldo-salt-induced aortic aneurysm by
inhibiting MR protein upregulation and nuclear translocation via ER in EC in the aorta in female mice with Ovx
and nicotine; Aim 2 is to determine whether targeting the Per2/MR/ICAM1/Nφ signaling can protect female
mice with Ovx or nicotine from Aldo-salt-induced aortic aneurysm. To achieve these goals, 12-week-old or 12-
month-old C57BL/6, iECERKO, Per2KO, iECPer2KO, iECMRKO, and WT control female mice will be
subjected to Ovx or nicotine and then treated with E2/progesterone (P4)/dihydrotestosterone (DHT)/ICAM1/
Ly6G antibody (Ab). The effect of hormone therapy, genetic deletion, and Ab blocking on aging/Aldo-salt-
induced AAA will be determined. The proposed studies will shed new mechanistic insight into the pathologies
of AAA in women and provide preclinical evidence to help identify new therapeutic targets against AAA.

Public health relevance
Project Narrative Abdominal aortic aneurysm (AAA) is a severe vascular disease affecting millions of Americans. Women develop AAA less and later than men, but AAA in women is more aggressive, with more rapid expansion, a higher tendency to rupture, and higher mortality following rupture. This application aims to investigate the mechanisms that underlie AAA in female mice and to identify new therapeutic targets to develop new drugs to treat AAA.